Training Program in Viral Diseases,Vaccines/ Biodefense

DESCRIPTION (provided by applicant): The goal of this proposed training program in Viral diseases, Vaccines, and Biodefense (WB) is to provide high quality training to outstanding applicants who will pursue investigative careers in these critical areas. The WB Program will be unique and demanding. It is designed to integrate training in viral diseases and vaccines, with particular concern for their relationship to biodefense. The Program will educate students in both virology and immunology and will bring basic and clinical scientists closer together to facilitate the conduct of translational research. The current training program has a long tradition of postdoctoral education in infectious diseases and immunology, primarily for individuals with MD degrees. The newly designed WB Program will take advantage of continuing strengths in viral diseases and vaccines, coupled with the recent and dramatic expansion in vaccine immunobiology research at Rochester to add a pre-doctoral component to the Program and more PhD recipients to its postdoctoral fellowship program. The pre-doctoral component will build upon a highly successful graduate program in the Department of Microbiology and Immunology, and will utilize the resources of a well-established, interdepartmental graduate training environment. In addition to course work required by the Virology or Immunology Tracks within the Department, WB students will be required to take the reciprocal basic course work in immunology or virology. Postdoctoral fellows will be required to have similar training; all VVB trainees will also take a course in basic epidemiology. Twenty two primary trainers will have principal responsibility for the bulk of the training, and have broad expertise in a variety of areas relevant to the VVB Program, including molecular biology of viruses, viral pathogenesis, clinical trials including evaluation of new vaccines, viral agents of bioterrorism, vaccine development, evolution of immunity, autoimmunity, B-cell biology, T-cell biology, and assay development for assessment of cellular immune responses. Sixteen resource faculty add expertise in epidemiology, biostatistics, access to patient populations for clinical studies, pharmacokinetics, animal models, and microbial pathogenesis. The integrity of the WB Program will be maintained by the WB Meeting, a weekly exercise with mandatory attendance that will include trainee presentations, a journal club, and an outside speakers program. The VVB Meeting will bring together all program faculty and trainees on a regular and frequent basis and will provide a forum for exposure to new ideas and the development of new collaborations.